Project 2: Radiation-Induced Lymphopenia: Understanding, Predictive Modeling and Developing Photon and Proton-Based Mitigation Strategies.

Project 2 - Summary
Radiation-Induced Lymphopenia: Understanding, Predictive Modeling and Developing Photon and
Proton-Based Mitigation Strategies
There is accumulating evidence across many types of cancers that radiation-induced lymphopenia (RIL) is
common, but it is often ignored as an unavoidable side effect. Severe RIL has been shown to correlate with
poor disease-specific outcomes. Extensive use of radiotherapy (RT) in the curative management of solid
tumors necessitates the development of RIL-mitigation strategies. We have compelling evidence of significant
differences in the lymphocyte-sparing effects of proton therapy (PT) vs. photon (or x-ray) therapy (XRT),
presumably attributable to the differences in their dose distribution patterns. Our work has further
demonstrated that both patient-specific and dosimetric factors contribute to the risk of severe RIL and T-cell
clonality. Our hypotheses are as follows: (1) RIL predictive models that account for individual patient
susceptibilities and dosimetric factors will have clinically significant predictive power; (2) reducing dose to
circulating immune cells and immune structures at risk preserves not only the quantity but, more importantly,
the quality of lymphocytes, which has a direct positive impact on cancer immunity and disease outcomes; (3)
through the utilization of intensity-modulated proton and photon RT (IMPT and IMRT), employing individualized
dosimetric constraints derived from the models, we will be able to select the optimum treatment modality
(protons or photons) and develop patient-specific strategies to substantially mitigate RIL and its consequences.
To test these hypotheses, we propose three specific aims. In Aim 1, we will utilize our large databases of
mainly esophagus, liver and brain cancer patients to improve our understanding of lymphocyte depletion as a
function of dosimetric and patient-specific baseline clinical factors and develop models to accurately predict
individualized severe RIL risk. In Aim 2, we will evaluate the clinical impact of the radiation treatment modality
on T-cell diversity, immune repertoire, and functional immune status. We will test the hypothesis that the
quality of lymphocytes as measured by immune phenotyping, T-cell diversity, and functional immunity after RT
is a major driver of clinical outcomes rather than just the absolute lymphocyte count. In Aim 3, we will assess
the validity of our models using independent retrospective and prospective data. We will also apply the models
to select the optimum treatment modality and technique for a given patient and define the personalized
dosimetric constraints to be used to optimize proton and photon radiation dose distribution patterns to minimize
RIL severity and risk. Upon the completion of this project, we will have a better understanding of how the
baseline clinical characteristics and proton and photon dosimetric factors impact RIL risk and severity, T-cell
diversity, and functional immunity. Moreover, we will have developed advanced proton and photon dosimetric
strategies to reduce RIL risk. Our research has the potential to better select the optimum modality for each
patient, to optimize IMPT and IMRT treatments to maximally mitigate lymphopenia to improve RT outcomes,
and to optimally integrate RT with immunotherapy strategies in the future.

Public health relevance
Project 2 - Narrative Radiation-Induced Lymphopenia: Understanding, Predictive Modeling and Developing Photon and Proton-Based Mitigation Strategies Radiation therapy (RT), a key pillar of cancer management, causes a common, yet often ignored, side effect – immune system suppression (i. e., radiation-induced lymphopenia [RIL]). Severe RIL has been linked to poor cancer treatment outcomes, presumably due to the reduced tumor surveillance by the immune system, thereby increasing disease recurrence and distant metastasis after RT. We propose approaches to identify clinical and dosimetric factors that predict the risk and severity of RIL and understand the impact of RIL on the immune diversity and profile as it affects clinical outcomes; to develop models that can accurately predict the risk of RIL individualized to a patient’s baseline clinical factors; and to use such models in the optimization of radiation dose distributions to mitigate RIL and its impact on outcomes.